Mechanisms of glucocorticoid-induced metabolic dysfunction in skeletal muscle

Abstract/Project Summary
Glucocorticoids are commonly prescribed as an essential drug regimen for anti-inflammatory modalities;
however, a major side effect of such therapies is the development of insulin resistance and risk for
hyperglycemia. Key contributors to insulin resistance induced by glucocorticoids are alterations in glucose and
lipid metabolism that negatively impact skeletal muscle. Glucocorticoids induce endogenous breakdown of lipid
from adipose tissue, releasing fatty acids into the circulation. Excess circulating lipids contribute to greater influx
into skeletal muscle, accrual of intramuscular lipids (e.g., ceramides, DAGs, TAGs, etc.), and induce a
pathological lipid burden on mitochondria. Excess intramuscular lipids also act as a competitive substrate to
carbohydrate metabolism and re-route glucose into hexosamine biosynthesis. The net result of these metabolic
changes ultimately impairs insulin signaling. While evidence supporting `lipotoxic' signaling molecules and
mitochondrial lipid overload leading to dysfunction are linked to insulin resistance, this concept has not been
investigated as part of the metabolic side effects of chronic glucocorticoid use. Our published and preliminary
data support the hypothesis that glucocorticoids promote insulin resistance by increasing the lipid burden within
skeletal muscle. To address this hypothesis, we propose the following strategies: In Specific Aim 1, we propose
to limit lipolysis-derived fatty acids from flooding into skeletal muscle using genetic models, which will provide
insights into glucocorticoid-mediated lipolytic events that influence insulin resistance. In complementary studies
proposed in Specific Aim 2, we will build on our novel preliminary data using skeletal muscle-targeted deletion
of Cpt1b (limiting mitochondrial fatty acid oxidation) to understand how restricting mitochondrial fatty acid
oxidation directly protects against glucocorticoid-induced metabolic dysfunction. Studies in Specific Aim 2 also
propose that excess cellular lipid uptake and hexosamine production act in a cooperative manner to potentiate
insulin resistance. We will use genetically modified mouse models to A) limit cellular lipid uptake in skeletal
muscle via deletion of the fatty acid transporter, Cd36, and B) limit hexosamine transfer to proteins in muscle
using deletion of O-GlcNAc transferase (OGT). Our novel data also supports the premise that elevated insulin
maintains lean mass and metabolic health in skeletal muscle. This will be tested using mice with skeletal muscle-
specific deletion of the insulin receptor. Finally, we propose the in vivo use of two novel, chemically synthesized
derivatives of hydrocortisone which function as glucocorticoid receptor agonists that retain anti-inflammatory
efficacy but are predicted to not induce adverse metabolic outcomes. These highly innovative studies, supported
by our preliminary data using both pharmacologic and genetic approaches, will provide unique mechanistic
evidence explaining one of the most deleterious side effects of chronic glucocorticoid usage and reveal insights
into strategies that can ideally be exploited to improve clinical outcomes of glucocorticoid therapy.

Public health relevance
Project Narrative Glucocorticoids are required to treat various diseases with inflammatory components. However, therapy with this class of drug leads to insulin resistance and diabetes. This project employs novel mouse models to define key cellular mechanisms relating to lipid metabolism in efforts to understand and eventually prevent these adverse effects to improve metabolic health.